Post-translational SOX2 modification - a regulatory switch between self-renewal and differentiation in squamous cell carcinoma

SUMMARY
SOX2 is a cell fate–determining transcription factor that is expressed in ~70% of cutaneous and head and neck
squamous cell carcinomas (SCCs) in patients. SOX2 is highly enriched in stem cell–like tumor-propagating cells
(TPCs), which are located within the basal SCC layer where they can self-renew or differentiate into suprabasal
SCC cells without proliferative potential. Although we know SOX2 controls the fate choice between TPC self-
renewal and squamous differentiation, it is unclear how its activity is regulated in SCCs and whether these
regulatory mechanisms could be developed into therapies for cancer patients. Here, we propose to test the
hypothesis that phosphorylation of SOX2 inhibits its activity, perturbs the SCC-specific SOX2-PITX1-
TP63 self-renewal circuit that drives clonal expansion and SCC growth, and thereby restores the KLF4-
dependent squamous differentiation program in SCCs. Our hypothesis is based on our preliminary studies,
which showed that SOX2 can be phosphorylated and that this phosphorylation attenuates its activity in SCC
cells. We propose to 1) test if SOX2 phosphorylation inhibits TPC self-renewal, clonal expansion, and SCC
growth; 2) identify the kinases and phosphatases that regulate SOX2 phosphorylation and function; and 3) define
the molecular mechanisms by which SOX2 activity governs TPC self-renewal, SCC growth, and differentiation
in mouse and patient-derived SCC models. We expect our proposed research will explain the fate choice
between TPC self-renewal and terminal differentiation on a molecular level and therefore provide new concepts
for the rational development of pharmacological approaches that enforce the commitment of TPCs to terminally
differentiate into SCC cells without proliferative potential.

Public health relevance
NARRATIVE SOX2 is as an essential driver of squamous carcinogenesis in mice and patients, but how its activity is regulated in these tumors remains unknown. We discovered that SOX2 can be phosphorylated in squamous cell carcinomas, and we propose to a) determine how SOX2 phosphorylation influences its activity, b) identify the kinases and phosphatases that regulate its function, and c) define the mechanisms by which SOX2 phosphorylation governs squamous carcinogenesis in mouse and patient-derived squamous cell carcinoma models. Once the function and regulation of SOX2 phosphorylation have been determined, we can begin to develop novel therapies that activate the kinases or inhibit the phosphatases to better treat the >20,000 squamous cell carcinoma patients who currently die from their disease in the United States each year.